Novel Genome Editing for the Treatment of Glaucoma

Abstract
Glaucoma is a heterogenous group of optic neuropathies and a leading cause of irreversible vision loss and
blindness worldwide. Primary Open Angle Glaucoma (POAG) is the most common form of glaucoma and is often
associated with elevated intraocular pressure (IOP), a leading causative risk factor for glaucoma. Elevated IOP
is due to damage to the trabecular meshwork (TM) that increases resistance to aqueous humor outflow. Current
glaucoma treatments do not address the underlying primary pathophysiological mechanisms and the disorder
can continue to progress despite treatment. To truly cure glaucoma, there is critical need to permanently inhibit
or reverse the glaucomatous damage to the TM and restore normal TM cell functions. New technologies,
specifically CRISPR/Cas9 genome editing, allow investigators to directly modify the genes associated with
pathogenic damage. We recently demonstrated the feasibility of targeting the mutant myocilin gene using
CRISPR-Cas9 genome editing to prevent and reverse glaucoma in myocilin-associated POAG in mice and in
human donor eyes. It is our goal to develop genome editing methods targeting the TM for the treatment of
myocilin-associated POAG, and importantly the treatment of POAG in general. We have a unique opportunity to
cure glaucoma by inhibiting the ongoing disease pathology by targeting common pathological pathways
associated with general POAG. We have previously linked the pathological role of endoplasmic reticulum (ER)
stress to the glaucomatous TM damage and IOP elevation in mouse models of ocular hypertension and in human
donor eyes. Specifically, we have shown that ER-stress induced ATF4 and CHOP are associated with
glaucomatous TM damage and independent inhibition of ATF4 and CHOP can be a novel treatment strategy for
general POAG. Therefore, we propose to target this common underlying mechanism using the CRISPR-Cas9
system. It is our overall goal to design AAV vectors encoding CRISPR/Cas9 targeting MYOC, CHOP and ATF4
to selectively knockout these genes in the TM and lower IOP in mouse ocular hypertension models, as well as
in ex vivo human perfusion organ cultured anterior segments. We hypothesize that genome editing knockout of
MYOC, CHOP and ATF4 using AAV.CRISPR/Cas9 vectors targeting the TM will prevent and reverse elevated
IOP in glaucoma. We will use AAV vectors because these agents have been used for gene therapy in patients
with specific eye diseases. In this proposal, we will first determine the most efficient AAV vector(s) for TM tropism
and design efficient CRISPR/Cas9 constructs that effectively knockdown MYOC, CHOP and ATF4 in the TM.
We will also evaluate CRISPR-Cas9 off-target effects in human donor eyes. Second, we determine the efficacy
of AAV.cr. MYOC, AAV.cr. CHOP and AAV.cr. ATF4 knockouts in the TM and the ability of these knockouts to
reduce elevated IOP in vivo in mice and ex vivo in human perfusion organ cultured anterior segments. Our
approach will revolutionize glaucoma therapy by directly interfering with glaucomatous damage to the TM and
provide a one-time therapy to effectively treat glaucoma resulting from elevated IOP.

Public health relevance
Project Narrative The successful completion of this project will lead to insights into disease mechanisms causing primary open angle glaucoma (POAG) including genetic and non-genetic forms of the disorder. Importantly, the results will pave the way for clinical application of molecular techniques, specifically genome editing of trabecular meshwork cells within the eye, to treat POAG alleviating the need for surgical and other medical treatments.